Proteomic profiling to identify mechanisms of susceptibility and resilience to cardiac dysfunction in Black Americans

Heart failure (HF) and atrial fibrillation (AF) are common and differentially burden Black Americans. Social
determinants of health (SDOH) also disproportionately impact Black Americans and contribute to an excess of
cardiovascular (CV) events, although many Black Americans survive to late-life free of CV disease. Critical
barriers to the development of interventions to prevent HF and AF include the limited knowledge of disease
pathobiology and of the molecular pathways by which SDOH and resilience to such adversity influence
susceptibility to CV disease. The objective of this proposal is to use proteomics and genomics to identify
biologic pathways that are responsible for the development of subclinical and clinical cardiac dysfunction, that
mediate the impact of SDOH on HF and AF risk, and that characterize biologic resilience to these outcomes
despite adverse SDOH. The central hypothesis is that integrated analysis of proteomic and genomic data in a
Black American population will enable discovery of novel inflammation- and fibrosis-related proteins relevant
to HF and AF development, and identify biologic pathways underlying SDOH-related risk for and resilience to
these CV conditions. The rationale is that identifying proteins with causal effects on cardiac dysfunction and
defining molecular mediators of CV resilience to adverse SDOH may yield new therapeutic targets that are
especially relevant to Black populations. This project leverages proteomics (~3,000 plasma proteins) measured
20 years apart, existing genomic data, rich CV phenotyping (echo, ambulatory arrhythmia monitoring), and
prospectively adjudicated events in the largest prospective CV cohort of Black Americans - the Jackson Heart
Study - to address the following aims: (1) Define proteins and protein networks associated with clinical and
subclinical cardiac dysfunction; (2) Identify proteins and protein networks associated with atrial fibrillation
and subclinical arrhythmia; (3) Identify molecular pathways linking SDOH, and resilience to adverse SDOH, to
cardiac function and arrhythmia in Black adults. The unique contribution of this project will be to identify
biologic mechanisms responsible for risk of and resilience to HF and AF in Black Americans. This contribution
will be significant because it will identify novel therapeutic targets for the prevention of cardiac dysfunction
tailored to disease mechanisms impacting Black Americans. These studies will therefore help to reduce the
morbidity, mortality, and racial disparity associated with HF and AF. Innovative features include: (a)
integration of repeated-measure proteomics and genomics to identify potentially causal proteins for cardiac
dysfunction and arrhythmia among Black Americans; (b) focus on an understudied population with excess
burden of CVD to interrogate mechanisms by which SDOH influence disease susceptibility; and (c) integration
of SDOH and psychosocial assessments to identify protective proteins underlying cardiac resilience in the face
of social adversity. Expected outcomes include advancing understanding of the biology of resilience and
discovery of therapeutic targets relevant to Black Americans.

Public health relevance
Project Narrative Heart failure (HF) and atrial fibrillation (AF) are urgent public health priorities whose incidence and prevalence increase with age and disproportionately burden Black Americans, who experience worse outcomes after either condition occurs. This proposal investigates the molecular pathways underlying HF and AF and the impact of social determinants of health in Black Americans, which will enable identification of novel targets for disease prevention. It therefore addresses several NHLBI strategic priorities including the integration of `omics' data with clinical and social exposures in understudied populations; identification of factors underlying resilience or susceptibility to HLBS disease; and use of multidimensional data to identify biologically distinct subgroups of cardiovascular aging.